Administration

ABSTRACT – Administration
The Administration component of the proposed P41 Center for Virtual Imaging Trials will provide key
infrastructure for all activities, including the three Technology Research and Development Projects, working in
coordination with the Center's Collaborative Projects and Service Projects, and the Technology Training and
Dissemination component. These components provide development, technical services, expertise, and training
activities to accomplish the overall goals of the Center. The Center's Administration will facilitate the work of all
components by fostering cross-Center synergy, providing oversight, and supporting communication. The
specific aims of the Administration component are to 1) provide scientific and administrative oversight and
management for the Center, 2) coordinate and integrate Center activities, 3) manage the software
infrastructure of the Center, 4) manage Center finances, and 5) facilitate evaluation of Center activities and
progress. Investigators will meet and discuss the Center projects and activities on a regular basis.
The Center will be led by the Principal Investigator, who will serve as Project Lead for the Administration
component, and by its Deputy Director serving as the Administration Co-Lead. Under the PI's leadership, the
Center will be governed by an Executive Committee that includes all Project Leads and Co-Leads. Monthly
Executive Committee meetings will address high-level scientific strategy, cross-component synergy and
coordination, and allocation of Center resources and funding. Quarterly meetings will be devoted to
interactions and reporting of Collaborative and Service projects. The Executive Committee will be advised by
an Internal Advisory Committee and an External Advisory Committee, each meeting annually. The Internal
Advisory Committee will consist of six leading scientists and administrators at Duke (Douglas, Johnson, Carin,
Pencina, Paulson, Sullivan) including an existing BTRC PI (Johnson) to ensure optimal contribution of Duke
resources to ensure the Center's success. The External Advisory Committee (to be selected in consultation
with the NIH) will consist of four senior scientist leaders in the areas of image processing, machine-learning,
imaging simulation, and clinical trials, with one member having served as a PI of a BRTC. These Advisory
Committees will evaluate Center progress and provide recommendations regarding its activities and priorities
including CP and SP selection and retirement. The Administration will provide effective infrastructure and
oversight to ensure that the Center meets its goals.